Administrative Core

Project Summary
The mission of the Maryland Polycystic Kidney Disease (PKD) Research and Translation Core Center (MPKD-
RTCC) is to remove barriers to PKD research by providing state-of-the-art reagents and expertise to a diverse
group of investigators. The MPKD-RTCC consists of 4 integrated biomedical research cores that have
generated key reagents required by investigators entering the field of PKD science. Here we establish a well-
organized Administrative Core that will provide direction, guidance and oversight for the MPKD-RTCC to
ensure that it functions effectively. The Administrative Core will be led by two accomplished senior
investigators, at The University of Maryland School of Medicine and at Johns Hopkins School of Medicine, who
will leverage the resources of both institutions. The Leadership team has extensive experience in the area of
polycystic kidney disease, renal physiology and in managing complex collaborative research grants and
scientific cores. The Administrative Core will oversee the financial operation of the Biomedical Research
Cores, monitor quality and throughput and ensure a streamlined MTA process that will promote the broadest
distribution of resources and expertise. In addition, the Administrative Core will coordinate ongoing research
endeavors between MPKD-RTCC cores that will advance the generation of new and innovative reagents. The
Administrative Core will continue to support a long-standing summer student program that will inspire trainees
to consider careers in nephrology and in PKD research. In addition the Center Leadership will organize an
integrated communications strategy to promote interactions between the MPKD-RTCC and all stake holders
including 1) a national research community 2) the Baltimore research community and 3) the Central
Coordinating site (CCS), other RTCCs and the NIDDK. We expect that this strong infrastructure will accelerate
the pace of scientific discovery in the field of polycystic kidney disease.